Administration Core

Core A: Administration Project Summary/Abstract
This Adult Children Study (ACS) Program Project Grant (PPG) renewal application represents the logical
evolution of our longstanding research interests in the interrelationships and predictive value of clinical,
cognitive, imaging, and fluid biomarker correlates of Alzheimer disease (AD) by exploring the transition from
cognitive normality to symptomatic AD and the mediators thereof. The Administration Core acts to ensure that
the research and programmatic goals of the ACS PPG are met. The administrative leadership consists of the
Director (Morris), Associate Directors (Benzinger and Xiong), and the Executive Director (Moulder). The
Administration Core supports, monitors, and coordinates the activities of all components of the ACS PPG. It
will annually convene an External Advisory Committee to review activities and progress. The Specific Aims are
to:
1. Coordinate and integrate the Cores and Projects and provide administrative and budgetary support and
oversight, ensuring appropriate utilization of funds.
2. Monitor the effectiveness of the ACS PPG toward achieving its stated goals.
3. Arrange for periodic external review and advice concerning ACS PPG goals and progress.
4. Coordinate and oversee data integration with Core D: Data Management and Biostatistics and the
Washington University Institute for Informatics to maintain and monitor an integrated database.
5. Facilitate the “Preclinical AD Consortium” and the “Alzheimer Disease Onset and Progression in
International Cohorts” efforts to harmonize data among key studies of preclinical AD.